Developmental genes, miRNAs and adipose tissue

Abstract
This is a competitive renewal of NIH grant DK082659 entitled “Developmental Genes, miRNAs & Adipose
Tissue”. Obesity is epidemic throughout the population and is a major driving force in the pathogenesis of type
2 diabetes, metabolic syndrome and many other disorders. Over the past decade, work supported by this grant
has shown that obesity depends not only on the balance between energy intake and utilization, but also on the
balance between energy storage in white adipose tissue (WAT) and energy expenditure in brown adipose
tissue (BAT). We have shown that both WAT and BAT are heterogeneous, in part due to intrinsic differences
between adipocytes in different depots and also through their dependence on insulin/IGF1/FoxO signaling. We
have demonstrated heterogeneity at the cellular level by clonal analysis of murine preadipocytes and by single
cell analysis of human preadipocytes. In important new studies, we have found that different adipose depots
differ in their expression of miRNAs and that there are alterations in miRNAs and miRNA processing in adipose
tissue in aging, obesity, and lipodystrophy. Furthermore, we have shown that adipose tissue is a major source
of circulating exosomal miRNAs; that these can regulate gene expression in other tissues, forming a novel
mode of adipose communication; and that this is, in part, regulated by sequence motifs within miRNAs which
govern their cellular retention vs. exosomal secretion. The specific aims for the next 5 years are:
Aim 1: Define the interactions between adipocyte heterogeneity, insulin signaling and exosomal
miRNA mediated cellular communication. We will define the role of insulin in regulation of adipocyte miRNA
expression and exosomal secretion and determine differences between subtypes of WAT and BAT. We will
study the effects of BAT activation, obesity and weight loss In both mice and humans. We will determine if the
recently defined EXO and CELL motifs and RNA binding proteins involved in miRNA sorting play a role in
these processes, and explore the role of exosomal tRNA fragments, as a new class of regulatory small RNAs.
Aim 2: Use UPRT labeling and hCD63 to directly track exosomal miRNAs and exosomes in vivo.
With these, we will determine the relative contributions of BAT and WAT to the pool of circulating exosomes
and exosomal miRNAs and how these change during cold exposure, feeding/fasting, and in obesity. We will
also explore the role of insulin in vivo using the euglycemic clamp and tissue specific InsR knockout mice.
Aim 3: Enhance potential of miRNA therapeutics by manipulating exosomal sorting of miRNAs in
vivo. Taking advantage of our recent identification of motifs that modulate miRNAs cellular retention or
exosomal secretion, and using cholesterol/lipoprotein metabolism as a model, we will explore the role of
modifying miRNA or their sorting proteins for therapeutic purposes. Together with the studies above, this will
allow us to uncover how the exosomal miRNA communication system interacts with the endocrine system to
regulate metabolism, and how this may be used to treat disorders like metabolic syndrome and diabetes.

Public health relevance
Project Narrative Obesity is epidemic throughout the population and is a major driving force in the epidemic of type 2 diabetes, metabolic syndrome and many other disorders. This grant focuses on defining the interactions between adipocyte heterogeneity, insulin signaling and exosomal miRNA mediated cellular communication in the pathogenesis of these disorders. It also explores new techniques to directly track adipose-derived exosomes and their miRNAs, as well as their potential role as novel therapeutics.